Project 3: Membrane-bound mucins on the airway surface ensure efficient mucus clearance and lung health

The healthy airway epithelial mucosal barrier is the center of a powerful innate immune system that protects the
pulmonary surfaces from the constant onslaught of inhaled infectious and noxious substances. However,
abnormalities in the mucus clearance system characterize a number of airway diseases, including cystic fibrosis,
chronic obstructive lung disease, and asthma. The pathogenesis of these diseases is multi-factorial, but appears
to include a common disease-initiating step, a reduction of mucus clearance. We have developed a novel
paradigm describing the mucus transport system, referred to as the “two-gel” model, which highlights the role of
the two mucin-containing layers on the airway surface: 1) the mucus layer, containing secreted mucins which
bind inhaled particles; and 2) membrane-spanning tethered mucins – a layer referred to as the periciliary layer-
glycocalyx (or PCL-G) which lines the airway surface. We have previously shown that the failure to regulate both
layers is associated with a reduction in mucociliary clearance. However, it is currently unknown how the cilia and
PCL-G are organized to facilitate the efficient clearance of mucus out of the lungs and protect against inhaled
pathogens. The overarching goal of Project 3 of this PPG is to apply novel theoretical concepts and experimental
approaches to answer key questions about the multiple roles of the PCL-G with respect to both mucus transport
and the host barrier defense activities required to protect the airway surfaces. First, we seek to understand how
the mucus layer actually is transported, i.e., how momentum is transferred from cilia to the mucus layer. In Aim
1, we will test the hypothesis that in the distal airways, where mucins are too low to generate a viscoelastic gel,
water is “pumped out” of the periciliary space, providing hydrodynamic force sufficient to transport the dilute
mucus layer. Studies in this aim are directed at quantifying the water pumping forces generated by cilia beating,
assess whether they are sufficient to propel a low-viscosity mucus across airway surfaces, and understand the
impact of gravity. In Aim 2, we will test the hypothesis that in the larger airways, where mucin concentrations are
sufficient to form a viscoelastic gel, a second mode of cilia-mucus momentum transfer is required for efficient
mucus transport. Here, we hypothesize that the highly glycosylated tethered mucins on the tips of cilia form
weak/transient interactions with the mucus gel during the cilia power stroke and physically “thrust” the mucus gel
forward. Studies here will assess the impact of modulating tethered mucins on the efficacy of mucus gel transport
and how it is altered in disease. Studies in Aim 3 are directed at understanding the role that the densely packed
tethered mucins play in airway protection. We will test the hypothesis that tethered mucins lining the airway
surface form a physical barrier to prevent inhaled pathogens, including viruses, from penetrating the PCL-G
space. We anticipate that results from these studies will lead to paradigm shifts in our understanding of how
mucus clearance is maintained in health and aid in the discovery of therapeutic strategies which can
accelerate/restore clearance in persons with muco-obstructive lung diseases.